Mitochondrial DNA Injury is a Key Contributor to the Development of Chemical Lung Injury

Accidental exposure to chlorine (Cl2) causes potentially fatal lung injury accompanied, in survivors, by reactive
airway disease and pulmonary fibrosis resembling symptoms typical of the acute respiratory distress syndrome
(ARDS). Our preliminary data also document that the mitochondrial genome–the integrity of which is critical to
maintenance of normal bioenergetics and mitochondrial signaling activities– displays oxidative damage after Cl2
gas exposure, similar to that detected in other models of acute and chronic lung injury. Against this background,
here we propose to test the hypothesis that an early molecular target in Cl2 gas inhalation is the
mitochondrial (mt) genome, in which oxidative damage functions as a molecular sentinel leading to
activation of pro-inflammatory pathways that drive acute lung injury and progressive lung remodeling.
To address this hypothesis we will perform the following in vivo and in vitro studies outlined in the following three
aims: Aim 1. Define the kinetics of lung oxidative mtDNA damage in mice exposed to Cl2 gas and returned to
room air and test whether a novel agent to augmenting mtDNA injury decreases mortality and the severity of
acute and chronic lung injury. Exp. 1.1 will determine the time course of Cl2 gas-induced lung mtDNA damage
and its relation to lung pathophysiology in global (mitochondrial and nuclear) OGG1 knockout mice (OGG1-/-)
and their wild type (WT) controls (C57BL/6), along with OGG1 KO mice reconstituted with mito-targeted OGG1
(OGG1-/-+OGG1mt), while Exp. 1.2 will test if intranasal administration of mitoOGG1 at selected time points after
termination of Cl2 exposure decreases lung injury pulmonary fibrosis and improves survival. Aim 2: Test the
hypothesis that Cl2 gas-induced lung mtDNA damage triggers mobilization of mtDNA Damage Associated
Molecular Patterns (DAMPs) that drive nucleic acid-dependent inflammation and serve as biomarkers and
causative agents of pneumotoxicity. In Exp. 2.1 will use WT, OGG1-/-, and OGG1-/-+OGG1mt mice to test the
hypothesis that OGG1 activity coordinately regulates Cl2 gas-induced mtDNA DAMP accumulation and activation
of nucleic acid receptor-mediated pro-inflammatory pathways. Aim 3: Determine key cellular mechanisms by
which Cl2 gas causes mtDNA damage-dependent lung cell death and dysfunction. In Exp. 3.1 we will isolate
alveolar macrophages (AM) and lung epithelial type II cells (ATII) from WT, OGG1-/-, and OGG1-/-+OGG1mt
mice, and measure oxygen consumption rate, reactive oxygen species, mitochondrial membrane potential, ion
transport and key indices of cell injury prior to and following exposure to Cl2 gas. Additionally, Exp. 3.2 will define
the mtDNA damage-dependent trafficking of mtDNA DAMPs to cytosolic and extracellular compartments and
determine how these two mtDNA DAMP pools interact to dictate pro-inflammatory nucleic acid receptor
activation. As part of this experiment, we also will determine if exogenous mtDNA DAMPs recapitulate nucleic
acid receptor activation and inflammation evoked by Cl2 and use Dnase1 to degrade extracellular mtDNA DAMPs
to define the specific effect of mtDNA DAMPs originating from this compartment.

Public health relevance
PROJECT NARRATIVE Accidental exposure to the halogen gas, chlorine (Cl2), causes fatal lung injury characterized by profound airway inflammation, pulmonary edema and acute respiratory failure. Survivors often display persistent reactive airway disease and progressive pulmonary fibrosis. This study will determine if mitochondria DNA damage underlies Cl2 toxicity and whether repairing mitochondrial DNA can reduce morbidity and mortality.